Contrasting roles for neutrophils and macrophages during acute pyelonephritis

Project Summary/Abstract
Urinary tract infections (UTIs) are among the most frequent and severe infections worldwide. Uropathogenic
Escherichia coli (UPEC) is the primary causative agent of UTI. UPEC ascension from the bladder (cystitis) to the
kidneys results in pyelonephritis (PN). Despite prompt antibiotic treatment, patients with PN can develop acute
kidney injury (AKI) and renal scarring, which can ultimately lead to end-stage renal disease. Currently, no therapy
is available to prevent the long-term sequelae following PN.
The innate immune system serves instrumental roles in controlling UTI and represents a potential therapeutic
target for UTI prevention and treatment. However, mounting evidence argues that dysregulated innate immune
responses can lead to persistent inflammation and renal scarring during PN. A greater understanding of the
cellular immune mechanisms underlying the development of renal inflammation and kidney fibrosis during PN
will lead to novel therapeutic strategies to treat UTI and prevent the development of detrimental sequelae.
I have recently demonstrated that neutrophils and macrophages have distinct roles during PN pathogenesis.
While neutrophils prevent widespread UPEC dissemination, macrophages promote pro-inflammatory and pro-
fibrotic immune responses during PN. The overall objective of this proposal is to investigate the functional roles
of neutrophils and macrophages in the development of kidney fibrosis and dysfunction after a PN episode.
My central hypothesis is that neutrophils eradicate UPEC and prevent permanent kidney damage, while macro-
phage-mediated inflammation drives kidney injury and renal scarring during PN.
The specific aims during this K award will test the following hypotheses: 1) Neutrophils have a protective antimi-
crobial function, while macrophages induce interstitial fibrosis and renal dysfunction during PN (Aim 1). 2) Mac-
rophages exert pro-inflammatory and pro-fibrotic functions during PN, which contribute to renal inflammation,
scarring, and reduced kidney function (Aim 2). 3) Neutrophil NOX2 limits bacterial dissemination during PN,
whereas macrophage NOX2 promotes oxidative stress and kidney injury (Aim 3). The proposed research will
use an innovative preclinical mouse model of APN that replicates the development of kidney fibrosis following
UTI and bridges methodologies in the areas of immunology, microbiology, molecular biology, and nephrology.
The expected outcomes from this proposal will reveal novel biological functions for macrophages and neutrophils
during PN, and will identify new targets that may alleviate PN-mediated sequelae.
This approach in combination with structured career development activities under the guidance of my mentors
and research advisory team, will prepare me to successfully compete for R01 funding and launch my career as
an independent scientist focused on resolving some of the most challenging obstacles in the treatment of UTI.

Public health relevance
Project Narrative Ascending urinary tract infections (UTIs) commonly result in pyelonephritis (PN), which can lead to clinically significant renal scarring and functional impairment. To date, the cellular mechanisms underlying the development of renal fibrosis and kidney dysfunction following PN remain unknown. Our proposed research is relevant to public health because we will identify the mechanisms by which macrophages and neutrophils mediate the development of renal scarring following PN, which will allow us to establish the foundation for new treatment paradigms to prevent loss of kidney function in patients with PN.